The role of the melanocortin 4 receptor in control of breathing

This application is submitted in response to the PA-23-189 Research Supplements to Promote
Diversity in Health-Related Research (Admin Supp - Clinical Trial Not Allowed). The parent grant is
‘Melanocortin 4 receptor agonists to treat sleep disordered breathing in obesity’, R01HL174409-01, 07/01/2024
– 06/30/2028 with contact PI Vsevolod Y Polotsky, MD, PhD. Obesity hypoventilation syndrome (OHS) is a
severe form of sleep disordered breathing (SDB) characterized by daytime hypercapnia and hypoventilation
during sleep. There is no effective pharmacotherapy for OHS. Our parent grant is focused on respiratory effects
of the melanocortin 4 receptor (MC4R). MC4R agonists increase energy expenditure and suppress food intake
in obese rodents and humans. The MC4R agonist setmelanotide has been approved for treatment of genetic
forms of obesity linked to mutations in the POMC/MC4R/leptin pathways. Our data shows that (1) setmelanotide
(SET) robustly augments the hypercapnic ventilatory response (HCVR) and treats SDB in DIO mice and that
(2) chemogenetic activation of MC4R (+) neurons in the parafacial region (and specifically in the retrotrapezoid
nucleus, RTN) of the rostral ventrolateral medulla (RVLM) increases baseline ventilation and HCVR without any
effect on metabolism. The overarching hypothesis of the parent award is that MC4R agonists treat OHS
by augmenting hypercapnic sensitivity in MC4R+ neurons of the parafacial region, which is a major
center of CO2 sensitivity. However, one important question remains unaddressed: Is MC4R just a
marker of CO2 sensing neurons in the parafacial region or it mediates respiratory sensitivity? This
question will be addressed in our supplement providing a logical extension of the current award. We will use
diet induced obese (DIO) male and female mice, which possess loxP sites flanking the entire coding region of
the melanocortin 4 receptor (Mc4r) gene (Mc4rflox mice). MC4R deficiency in the parafacial region will be induced
by stereotactic transfection of adeno-associated virus (AAV) carrying Cre-recombinase. Specific Aim 1 will
determine if MC4R in the parafacial neurons is necessary for normal breathing during sleep and for the
hypercapnic ventilatory response (HCVR) during sleep and wakefulness. We propose that MC4R deficiency in
neurons of the parafacial region will (A) induce SDB and (B) attenuate the HCVR during sleep and wakefulness
without any change in metabolism. Specific Aim 2 will determine how MC4R deficiency in the parafacial neurons
impacts on respiratory and metabolic effects of SET. We propose that MC4R deficiency in neurons of the
parafacial region will abolish beneficial effects of SET on (A) SDB and (B) the HCVR during sleep and
wakefulness without any change in metabolism. The research delineated in the supplement is not an expansion
(change in scope) of the parent grant requiring peer review.

Public health relevance
Obesity hypoventilation syndrome (OHS), accumulation of carbon dioxide in the body, is the most severe form of sleep disordered breathing, which does not have effective drug therapy. In the parent grant, we will examine a role of melanocortin 4 receptor (MC4R) receptor in stimulating breathing in OHS. The supplement will show if MC4R in the particular area of the brain, can be a drug target to treat OHS.